Epigenetic mechanisms linking psychosocial stress with coronary heart disease

PROJECT SUMMARY
Elevated psychosocial stress – a hallmark of modern, fast-paced societies – has been repeatedly associated
with altered immune function and increased coronary heart disease (CHD) risk, but the mechanisms underlying
these associations are unclear. DNA methylation, one of the critical and most studied epigenetic processes in
humans, has emerged as a key link between environmental exposures and human health. Our long-term
goal is to elucidate the epigenetic and other molecular mechanisms through which psychosocial stress
contributes to atherosclerotic disease. The overall objective of this application is to define the methylomic
differences associated with stress both in whole blood and in distinct immune cell types and to determine how
these differences can shape immune function and predict CHD risk. The central hypothesis is that stress
drives methylomic patterns that epigenetically upregulate proinflammatory and other immune mediators across
distinct blood cell types, thereby contributing to incident CHD. The rationale for this application is that determining
stress-associated epigenomic patterns and their functional sequelae in peripheral blood immune cells can yield
novel composite predictors and molecular targets that can be leveraged to enhance CHD prevention and
treatment. The central hypothesis will be tested by combining large-scale analyses in human cohorts and
mechanistic investigations in cell models. Three distinct but complementary specific aims will be pursued: 1)
Identify stress-associated methylomic profiles in whole blood that predict incident CHD; 2) Define cell type-
specific methylomic patterns that are associated with stress and predict CHD; and 3) Mechanistically dissect
how stress epigenetically regulates monocyte function in culture. Aims 1 and 2 will leverage multiple large cohort
studies that participate in the NHLBI Trans-Omics for Precision Medicine (TOPMed) program and have suitable
psychosocial stress, whole-blood DNA methylation, and/or incident CHD data. Cell type-specific methylomic
patterns will be deconvoluted using cutting-edge computational methods recently developed by the research
team. Key epigenetic signals will be mechanistically dissected using cell models of monocytes and monocyte-
derived macrophages undergoing exposure to physiological levels of stress hormones and targeted DNA
methylation editing in culture. This interdisciplinary proposal is innovative as it will integrate large-scale
association efforts that apply novel computational methods across multiple TOPMed studies with cutting-edge
mechanistic work in immune cell models. The proposed research is significant as it is expected to yield innovative
epigenetic predictors and actionable molecular targets that can be leveraged to enhance prevention and
treatment of stress-associated CHD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it is expected to identify novel epigenetic predictors and targets of stress-associated coronary heart disease (CHD), thereby opening new horizons towards personalized interventions that can beneficially modulate the epigenome of individuals experiencing high stress levels and CHD risk. These expected contributions are relevant to NHLBI’s mission as they have the potential to enhance prevention and treatment of CHD, which is the single leading cause of death in the United States.